CRCNS: Building and testing computational models of the neural basis of natural communication

Communication and language processing disorders can significantly impact the lives of millions of people.
The proposed Conversations project will combine an unprecedented ECoG dataset and a cutting-edge MLbased encoding framework to test competing models for neural mechanisms supporting natural language
processing and face-to-face communication in natural contexts. Uncovering the neural mechanisms behind
everyday communication can give voice to people with speech and hearing impairments, shed light on
communication disorders, and enhance doctor-patient communication. In Aim 1, we will create the "24/7
Conversations" dataset of 750 hrs of continuous electrocorticography (ECoG) data from epilepsy patients
engaging in free daily life conversations. This dataset will be the largest collection of real-life conversations
and intracranial neural activity assembled. Aim 2 involves developing an ML-based encoding framework to
test the ability of various language models to model our "24/7 Conversations" dataset. ML-based encoding
framework will allow us to explore brain-to-brain communication dynamics during face-to-face
conversations. Finally, Aim 3 will leverage the ML-based encoding framework to construct novel
computational models that simulate the neural basis of natural language processing, focusing on how the
brain predicts and integrates spoken language during spontaneous real-life conversations. Through these
efforts, we aim to map the intricate neural activities associated with language, providing insights into normal
and disordered communication.

Public health relevance
RELEVANCE (See instructions): Millions of people are affected by communication and language processing disorders. This research aims to develop new machine-learning models to analyze typical and atypical language patterns using neural responses recorded during real-life conversations. The goal is to create targeted interventions for people with speech and language disabilities and develop tools to support individuals with communication disorders, including aphasia, dysarthria, or stuttering.